Novel Transparent, Ultra-soft Neuroelectrode Arrays Based on Nanomeshing Conventional Electrode Materials SUPPLEMENT

Abstract
The objective of our parent award RF1NS118301 is to develop and validate proof-of-concept, nanomesh-
microelectrode-based, transparent, ultra-soft, high-density (NANOMESH) array with at least 256
high-performance nanomesh microelectrodes and artifact rejecting wireless data link. The proposed
dissemination supplement is within the scope of the parent award, but beyond the original dissemination plans.
As the focus of the parent award is to generate proof-of-concept for NANOMESH arrays, we decided at the
time when applying for our parent award that a plan for dissemination of proposed technology in it may be
premature. Over the past project duration, PI Fang’s lab has established the fabrication and testing of flexible
nanomesh microelectrode arrays (MEAs) with up to 256-ch in wired connections. Although the parent award
aims to achieve also ultra-softness for the arrays in addition to fully wireless system, wire-connected
nanomesh MEAs are still highly useful and particularly suitable for electrophysiology applications with
concurrent in vivo imaging, where the animals are going to be head-fixed anyway. This dissemination will not
only fulfill some urgent needs in the community for such electrode arrays, it will also in turn, provide valuable
feedback on both the further technology development and how to best disseminate novel neuroelectronic
devices. Consequently, we feel it’s appropriate to pursue small dissemination efforts of our existing and/or
easily-achievable wired, soft nanomesh MEAs, which will significantly benefit three end-user laboratories, while
being highly synergistic with the parent award.
This grant supplement will significantly facilitate the intended small dissemination efforts by (1) providing
two pieces of equipment that will scale-up and automate the device fabrication process of soft nanomesh
MEAs, (2) purchasing materials and supplies for building additional devices, (3) supporting research assistants
in the PI’s lab to conduct training on the soft nanomesh MEAs being disseminated and their
handling/utilization, and (4) supplying dedicated recording systems for one of our end-users for chronic
experiments.

Public health relevance
Project Narrative In this study, we propose to prove a novel electrode concept, nanomeshing conventional electrode materials, can lead to state-of-the-art electrophysiological capabilities while allowing at the same time, optical and chronic-bio- compatibilities. Besides enabling new hypothesis-driven neuroscience studies from overcoming major barriers of integrating in vivo electrical recordings with optical approaches, the proposed research will also provide unique opportunities for next-generation therapeutic interventions via sustainable neural prosthetics.